Novel designs for multi-arm multi-dose multi-stage platform trials

Project Summary/Abstract
The drug development process is an intricate and resource-intensive endeavor, particularly in the context of addressing
complex diseases with unmet medical needs, such as cancer, serious rheumatic diseases, acute ischemic stroke, among
others. There has been a surge in the development of new therapeutic agents and combination treatment strategies,
driven by rapid advancements in biological knowledge. However, the conventional approach to clinical trials, where
treatments are evaluated one at a time in a sequential manner, is fraught with several shortcomings, especially in the era
of precision (personalized) medicine. This \one-treatment-at-a-time" paradigm in drug development is associated with
notably low success rates. It not only consumes valuable time and resources between separate trials but also extends the
overall drug development timeline. The discrete nature of these phases impedes the ecient exchange of information
across di erent stages, potentially leading to a loss of overall eciency. Furthermore, the evaluation of multiple
treatments individually presents challenges in accurately estimating and interpreting the relative treatment e ects of
each drug due to the presence of \treatment{trial" confounding. Viewing the drug development process as a whole
system, the multi-arm multi-stage platform trial provides an e ective way to eciently evaluate modern treatments.
Platform trial can eciently evaluates treatment by quickly advancing promising ones and discarding ine ective or
overly toxic ones. This reduces the time it takes to identify e ective treatments for patients in unmet medical need.
Platform trials can easily add new treatment arms, enabling continuous adaptation and optimization. Additionally, they
control family-wise false positives and increase eciency with methods like multiple testing procedures and adaptive
randomization to allocate more patients to better treatment arms, among other prominent bene ts. During recent years,
several well-known platform trials have been conducted to advance drug development. These trials include I-SPY2 for
breast cancer, REMAP-CAP for pneumonia, and DIAN-TU for Alzheimer's disease, among others. Additionally, during
the COVID-19 pandemic, more than 50 COVID-19 platform trials were registered globally between 2020 and 2021. In
response to the growing prevalence of platform trials, this research aims to propose robust Bayesian adaptive designs and
methods to address the practical challenges that arise in real-world platform trials. These challenges include optimizing
sequential monitoring of multiple treatments and/or multiple endpoints, eciently establishing proof-of-concept and
dose selection in multi-arm multi-dose platform trials, managing incompatibility issues due to non-concurrent controls,
and addressing late-onset outcomes, among others. Each proposed method will be tailored to tackle a combination of
these challenges in speci c platform trial settings. For each design, user-friendly software will be developed, which will
include programs for trial simulation to establish design operating characteristics, facilitate trial conduct, and assist
physicians in selecting optimal treatment for their patients. The overarching goal is to develop Bayesian adaptive
methods to identify superior treatments or doses across various diseases and clinical settings, ultimately aiming to
achieve greater anti-disease e ects, improved safety, and enhanced survival outcomes.

Public health relevance
NARRATIVE The proposed research aims to develop novel methods and trial designs for assessing multiple treatments in real-world platform trials across various diseases, addressing practical challenges encountered in such trials including optimizing the monitoring of multiple treatments and/or multiple endpoints, eciently determining proof-of-concept and dosages in multi-arm multi-dose trials, managing issues related to non-concurrent controls, and dealing with late-onset outcomes. Each method will be developed using innovative Bayesian approaches and made robust under various assumptions and settings, and will be accompanied by user-friendly software for trial design and conduct, making them accessible for broad application. The ultimate goal is to provide ecient and adaptive decision-making tools for evaluating treatments, leading to better disease management, increased survival, and enhanced patient safety.